Investigating the safety and efficacy of pillararene sulfates as novel and effective reversal agents for both steroidal and non-steroidal neuromuscular blocking agents.

Abstract
Reversal Therapeutics, Inc. (Reversal), a Maryland-based pre-clinical company, is advancing the development
of PILLAR[6]MAXQ (P6AS), a novel supramolecular sequestration platform designed to address the limitations
of current neuromuscular blocking agent (NMBA) reversal agents. NMBAs are commonly used in surgical
anesthesia, and while sugammadex (Bridion®) is the standard reversal agent, it is ineffective against non-
steroidal NMBAs like cisatracurium. P6AS, a patent-pending reversal agent, has demonstrated potential to
overcome this limitation by safely and effectively sequestering both steroidal (rocuronium, vecuronium) and non-
steroidal NMBAs, offering a broader reversal spectrum. The project’s primary objective is to evaluate the safety
and efficacy of P6AS and derivative analogues as reversal agents for both steroidal and non-steroidal NMBAs.
Specifically, the project aims to: i) Develop and evaluate P6AS analogues to identify those with high affinity (100
nM) for both steroidal and non-steroidal NMBAs; ii) Test the biocompatibility of selected compounds in kidney
and liver cells to assess their in vivo efficacy in reversing NMBA effects; and iii) Characterize P6AS and derived
analogues’ pharmacokinetics, including absorption, distribution, metabolism, and excretion, in rodent and non-
rodent species. The expected results of this project are to advance P6AS and potentially derivative analogues
toward clinical application, addressing a critical gap by enabling fast acting reversal of non-steroidal NMBAs and
potentially improving surgical outcomes.

Public health relevance
Project Narrative Reversal Therapeutics, Inc. aims to advance PILLAR[6]MAXQ (P6AS) and analogues, comprising a novel supramolecular sequestration platform, to overcome the limitations of current neuromuscular blocking agent (NMBA) reversal agents. This project will assess P6AS safety and efficacy in reversing both steroidal and non- steroidal NMBAs, focusing on developing high-affinity analogues, evaluating biocompatibility, and characterizing pharmacokinetics in various species, with the goal of enhancing surgical outcomes through broader NMBA reversal capability.